Understanding mechanisms of impaired immunity in the AML bone marrow

PROJECT SUMMARY/ABSTRACT
Immune-based treatments for acute myeloid leukemia (AML), an aggressive hematologic malignancy that
remains fatal for over half of the 20,000 patients diagnosed in the United States annually, remain an unmet
clinical need. The impetus to use T cell-based immunotherapy approaches for AML treatment is underscored
by the curative potential of allogeneic hematopoietic cell transplantation for AML, arising from immune-
mediated graft-versus-leukemia activity of donor T cells, and by emerging correlative data between the
immune landscape and AML treatment efficacy. Understanding mechanisms of ineffective anti-leukemic T cell
activity in the AML bone marrow (BM), the site where AML emerges, is fundamental for advancing
immunotherapeutic approaches for AML. Our preliminary data highlight the immunosuppressive nature of T
cells within the AML BM, the dynamic evolution of T cell clones with regard to states of T cell activation and
exhaustion, and the immunomodulatory potential of malignant AML cells on T cells. We hypothesize that both
malignant and non-malignant cells in the AML BM promote impaired T cell immunity, leading to distinct T cell
compositions at different disease states. This career development program will address two specific aims: (1)
determine T cell intrinsic features that affect the relationship between T cell phenotype, repertoire, and disease
status in the AML BM, and (2) understand mechanistically how malignant (AML blasts) and non-malignant cells
in the AML BM shape features of the T cell compartment.
The candidate has developed this proposal as an extension of her ongoing T cell studies in hematologic
malignancies and clinical experience in AML. During the award period, she will complete her research with
close counsel from her primary mentor, Omar Abdel-Wahab, MD, an accomplished scientist in leukemia
biology and genomics who is the Chair of the MSK Molecular Pharmacology Program. Additional input will be
offered by her co-mentor, Marcel van den Brink, MD, PhD, an international expert in T cell biology in
hematologic malignancies, and by her Advisory Committee. Drs. Abdel-Wahab and van den Brink are both
mentors with outstanding records of navigating physician–scientists toward research independence. Under
their guidance, the candidate will develop skills that are critical for her future laboratory program, including
learning to generate and analyze syngeneic mouse models of AML, to build upon her knowledge of functional
studies with primary AML samples, and to advance her computational and bioinformatics abilities in
sequencing-based immunologic techniques. Completion of this proposal will provide the candidate with the
training and mentorship required to cultivate and refine her expertise in T cell immunology and leukemia
research and to establish her academic career as an independent laboratory-based clinical investigator
dedicated to advancing immunologic treatments for AML.

Public health relevance
PROJECT NARRATIVE Immune-based therapies have transformed the treatment of many hematologic malignancies, but such approaches have had limited success for acute myeloid leukemia (AML), an aggressive hematologic malignancy that remains fatal in nearly half of diagnosed cases. However, there is great potential for T cell- based immunotherapeutic approaches for treating AML given (1) studies demonstrating impaired T cell immunity in AML patients, (2) clinical data illustrating correlation between the bone marrow immune landscape and treatment responses to both chemotherapy and immunotherapy, and (3) the curative potential of allogeneic hematopoietic cell transplantation for AML arising from the immune-mediated graft-versus-leukemia activity of donor T cells. The goal of this study is to perform deep analysis of T cells in parallel with surrounding populations in the bone marrow, the site where AML emerges, to elucidate key mechanisms driving T cell functional responses to AML longitudinally, and to identify immunologic targets for potential therapeutic intervention.